Impact of malaria vector diversity on intervention strategies

PROJECT SUMMARY
The burden of malaria in Malawi is among the highest in the world despite increasing coverage of standard
interventions over the last two decades. One factor that contributes to continued parasite transmission is the
diversity of malaria vectors, yet important aspects of this diversity remain poorly characterized. The Principal
Investigator, Dr. Robert McCann, is a vector biologist in the Malaria Research Program at the University of
Maryland School of Medicine. He will use a combination of field and laboratory data together with advanced
computational methods to address these gaps through three specific aims. Aim 1 will characterize vector
competence in Anopheles funestus and Anopheles arabiensis, the two dominant malaria vector species in
Malawi, using experimental membrane feeding assays with field-collected An. funestus and An. arabiensis. Aim
2 will assess the impact of species-level variation in vector competence on malaria intervention effectiveness
using an agent-based stochastic model to compare malaria intervention effectiveness under scenarios with a
range of variation in mosquito susceptibility to P. falciparum infection. Aim 3 will determine the relationship
between geographic proximity and genetic relatedness for malaria vectors in Africa using geospatially informed
bioinformatics tools to estimate migration patterns of malaria vectors. The results from these studies will improve
our understanding of the persistence of malaria parasite transmission.
Dr. McCann’s goal is to become an independent investigator in vector ecology, while maintaining the
strong interdisciplinary collaborations necessary to make advancements in malaria intervention design,
implementation, and evaluation. Towards this goal, he proposes a comprehensive career development plan that
will enhance his existing skills in malaria vector ecology while providing mentored training in 1) experimental
infection assays, 2) agent-based infectious disease modeling, 3) spatially explicit genetic and genomic analyses,
and 4) professional development with a special focus on leading international research.
Dr. McCann has assembled a highly accomplished and multidisciplinary team of mentors and
collaborators with unique areas of expertise including global health research, malaria transmission, vector
biology, genomics and bioinformatics, population genetics, infectious disease modeling and geospatial science.
His mentors also have a track record of successfully mentoring trainees and junior faculty and strong connections
with malaria policy stakeholders. The University of Maryland School of Medicine and The Malaria Alert Center
in Malawi will together provide the ideal environment for Dr. McCann to establish a research niche addressing
critical gaps in knowledge about malaria vector biology that will lead to improved malaria control in Malawi and
other malaria-endemic countries.

Public health relevance
PROJECT NARRATIVE Differences in the responses of mosquito populations to malaria interventions, both within species and between species, may impact intervention effectiveness, yet important aspects of this diversity remain poorly characterized. In this study, I will use a combination of field and laboratory data together with advanced computational methods to examine differences in vector competence between mosquito species and migration patterns within mosquito species. The results will improve our understanding of the current persistence of malaria parasite transmission.